Physical Activity Measurement in Toddlers

Project Summary
Physical inactivity is a significant health problem, affecting females more than males. Physical inactivity tends
to track over time and many young children aged 3 or 4 years are physically inactive. Therefore, understanding
when and how physical activity habits develop requires investigation starting at age 2 years or younger. In
toddler (age 1 or 2 years) physical activity research, however, a major methodological gap exists regarding
physical activity measurement, particularly related to accelerometer data processing. This gap limits our ability
to accurately estimate physical activity levels among toddlers. To process accelerometer data, an intensity-
based accelerometer count cut-point approach has been widely used. However, the cut-points suggested for
toddlers have been found to present low accuracy (≤58%). A new analytic approach, machine learning, has
been shown to provide more accurate activity classification among preschoolers and older children. Our pilot
study also suggests that the machine learning approach has great potential for toddler activity recognition. The
overarching goal of this proposed study is to better understand the development of physical activity behavior in
early childhood using an accurate physical activity measurement tool. The first aim is to develop and validate
an accelerometer-based machine learning algorithm for toddler activity recognition. The second aim is to
describe the trajectory of physical activity levels from age 12 to 36 months by sex. To achieve these aims, we
will recruit 124 children at approximate age 12 months from various pediatric clinics in Chicago and conduct
five waves of assessments at participant age 12, 18, 24, 30, and 36 months (waves 1 to 5). We will collect
accelerometer and video data (ground truth) in five free-living settings (home, childcare class, indoor playroom,
outdoor playground, and car-ride) in waves 1 to 4. The data will be split into a training set and a testing set.
The training dataset will be used to develop an activity recognition algorithm and the testing dataset will be
used to evaluate the newly developed algorithm. We will also conduct 7-day accelerometer assessments at
each of the five waves. Applying the algorithm developed in AIM 1, we will estimate daily time spent in
walking/running (minutes/day) and overall physical activity (minutes/day). We will use growth curve models to
examine the trajectories of walking/running time and overall physical activity time over age between 12 and 36
months, including sex as a predictor. This study will help to fill the methodological gap in toddler physical
activity measurement and expand the body of knowledge in early childhood physical activity.

Public health relevance
Project Narrative Physical activity has numerous health benefits. Physical activity behaviors develop from very early childhood. This proposed project aims to develop an analytic tool to recognize the activity types of toddlers, such as walking/running, standing, sitting, and being carried by an adult. The analytic tool developed will be useful to accurately evaluate physical activity levels among toddlers.